Development of a vaccine for Ebola virus in plant system

[unreadable] DESCRIPTION (provided by applicant): There are no vaccines to prevent infections by Ebola virus, although it is among one of the most feared pathogens worldwide. The research proposed herein will advance development of vaccine candidates, with emphasis on technology that will create pilot lots of vaccine for preclinical testing and cost-saving scale-up capability using transgenic plants for safe production of strategic vaccine reserves. The proposed research exploits the facile capacity of plant cells to express and accumulate complex proteins that are not currently available via other expression systems. The research builds upon an ongoing funding investment by DoD directed to the creation of a "cocktail" of monoclonal antibodies (MAbs) to use in post-exposure prophylaxis for Ebola virus infections; the DoD project utilizes transgenic plants because plant-derived MAbs can be rapidly expanded in commercial production without high-capital cost investments for traditional MAb production facilities. Recent research has shown that MAbs expressed in plant cells can be created as fusion molecules with antigenic protein domains as a C-terminal extension of the constant region of the antibody heavy chain. Highly immunogenic recombinant immune complexes (RICs) form when the variable region of the MAb recognizes the antigenic region of the fusion molecule. We will utilize three different MAbs to create RICs containing the sequences of the Ebola virus glycoprotein (GP) as well as GP fusions. Prototype vaccines will be produced in quantities sufficient for preclinical trials. Industrial participants of the application will develop purification technology for injected vaccines. An existing murine model will be utilized for immunogenicity and challenge trials, which will be followed by non-human primate vaccine evaluation of the lead vaccine candidates. [unreadable] [unreadable]